A Novel Mechanism Affecting Sex Differences in Adiposity

PROJECT SUMMARY
Males and females differ in adipose tissue development and function, which leads to differences in susceptibility
to metabolic disorders such as type 2 diabetes. In addition to the appreciated roles of sex hormones as
determinants of sex differences, the Reue lab previously showed that the presence of XX or XY sex
chromosomes plays an important role in determining adiposity. Particularly, the presence of two X chromosomes
is associated with increased body weight and fat tissue. This led to the hypothesis that some X chromosome
genes that have different expression levels in males and females are effectors of sex differences in adiposity.
Most X chromosome genes are expressed only from one X chromosome in both sexes, since in females the
second X is inactivated. However, certain genes escape X chromosome inactivation and are expressed at higher
levels in XX compared to XY cells. One such X chromosome inactivation escapee gene is Kdm5c, a member of
histone 3 lysine 4 demethylases. In 3T3-L1 preadipocytes, the KDM5 family is required for the activation of the
pro-proliferative cell cycle genes that are essential for the early stages of adipocyte differentiation. Importantly,
treatment of the 3T3-L1 pre-adipocyte cell line with shRNA against Kdm5c blocks differentiation to mature
adipocytes. In vivo, female mice with global Kdm5c haploinsufficiency in all tissues have reduced adipose tissue
compared to wild-type littermates. Consistent with Kdm5c dosage having an influence on adipocyte gene
expression levels, RNA-sequencing analysis of an adipocyte cell line showed that induction of enhanced Kdm5c
expression altered mRNA levels of several metabolic genes. The proposed studies will further characterize the
effect of Kdm5c dosage on adipogenesis and adipocyte gene expression. 1. Investigate the physiological
mechanisms by which Kdm5c gene dosage affects adiposity. 2. Uncover the molecular mechanisms through
which Kdm5c dosage affects adipocyte differentiation in vivo. The realization of this proposed project will
significantly augment our understanding of physiological and molecular mechanisms that influence sex
differences in adiposity and metabolic disease. In particular, they will shed light on a novel basis for sex
differences in epigenetic regulation due to intrinsic genetic differences that exist between XX and XY adipocytes.
Additionally, I suspect that these mechanisms will be important across tissues and will contribute to sex
differences in many phenotypes that differ between males and females.

Public health relevance
PROJECT NARRATIVE Despite long-term ongoing efforts to bolster diabetes awareness and prevention, the frequency of type 2 diabetes continues to grow. The observed sex differences in adiposity which further lead to distinct patterns in prevalence of type 2 diabetes can be utilized to explain the predisposing factors of this condition. My proposed studies will provide insight into both physiological and molecular mechanisms that influence sex differences in adiposity and metabolic disease due to intrinsic genetic differences that exist between XX and XY cells.